Mechanotransduction in C elegans

DESCRIPTION (provided by applicant): The long-term goal of this project is to characterize the post-synaptic mechanisms regulating synaptic transmission, particularly those that occur during homeostatic plasticity. At central synapses, changes in expression of post-synaptic receptors are thought to occur during activity-dependent plasticity, including homeostatic plasticity. We developed C. elegans as a model to study trafficking of an ionotropic glutamate receptor (GluR) GLR-1 at central synapses. We showed that GLR-1 levels are up regulated during activity blockade, a model for homeostatic plasticity, that clathrin-mediated endocytosis is required for this compensation, and that GLR-1 is sorted into either of two post-endocytic trafficking pathways (recycling versus degradation). Ubiquitylation of GLR-1 promotes its trafficking into the degradation pathway whereas RAB-2 promotes sorting into the recycling pathway. At neuromuscular junctions (NMJs), retrograde signals from muscles regulate the growth, stability, and strength of their motor neuron inputs. We identified a novel retrograde signaling pathway whereby increased muscle activity induces a muscle transcription factor (MEF-2), and MEF-2 in turn induces a retrograde signal that decreases presynaptic release of neurotransmitter. Here, we propose three aims to characterize these two forms of homeostatic regulation. First, we will determine which Rab proteins regulate GLR-1 trafficking. Rab GTPases regulate specific steps in protein transport; consequently, Rab mutant phenotypes will allow us to experimentally define discrete steps in GLR-1 trafficking. We are particularly interested in endosomal Rabs, because changes in endosomal trafficking have been implicated in activity dependent plasticity. Second, we will determine how the MEF-2- dependent retrograde message is regulated by muscle activity. We will test whether changes in endogenous muscle activity alter MEF-2 transcriptional activity, whether this is mediated by activity-dependent dephosphorylation of MEF-2 by calcineurin, and if MEF-2 activity is specifically coupled to nicotinic acetylcholine receptors. Third, we will identify genes that act downstream of MEF-2, and are required for the MEF-2-dependent retrograde message. One such gene (aex-1) was identified in preliminary studies. In summary, our experiments will provide new insights into the specific post-synaptic mechanisms underlying two forms of homeostatic regulation. Given the strong conservation of these pathways across phylogeny, it is likely that our experiments will provide new insights into the general mechanisms underlying these fundamental aspects of synaptic cell biology.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal describes a coherent set of genetic, biochemical, and biophysical experiments designed to characterize post-synaptic mechanisms regulating synaptic transmission, and in particular those underlying homeostatic plasticity. Homeostatic plasticity refers to a set of compensatory mechanisms whereby synaptic transmission is adjusted to compensate for long-term perturbations in activity. Homeostatic plasticity has been proposed to play a pivotal role in several aspects of circuit development and function. By examining mutant animals in which these compensatory mechanisms are inactivated, our experiments will allow us to critically evaluate these models. 7. Project Narrative: This proposal describes a coherent set of genetic, biochemical, and biophysical experiments designed to characterize post-synaptic mechanisms regulating synaptic transmission, and in particular those underlying homeostatic plasticity. Homeostatic plasticity refers to a set of compensatory mechanisms whereby synaptic transmission is adjusted to compensate for long-term perturbations in activity. Homeostatic plasticity has been proposed to play a pivotal role in several aspects of circuit development and function. By examining mutant animals in which these compensatory mechanisms are inactivated, our experiments will allow us to critically evaluate these models. __SpecificAimsTextDelimiter__ A. Specific Aims The long-term goal of this project is to characterize the post-synaptic mechanisms regulating synaptic transmission, and particularly those involved in homeostatic plasticity. One important mechanism for regulating post-synaptic activity is altering the sensitivity of post-synaptic cells to their inputs. At central synapses, changes in expression of post-synaptic receptors, and their insertion into the post-synaptic membrane are thought to occur during both short-term (i.e. Hebbian) and long-term (i.e. homeostatic) plasticity. At neuromuscular junctions, changes in muscle size and depolarization regulate the growth, stability, and strength of their inputs. These pre-synaptic changes are thought to occur as a consequence of retrograde signals, whose activity is induced by changes in muscle depolarization. During prior funding periods, we developed C. elegans as a model to study mechanisms regulating trafficking of an ionotropic glutamate receptor (GluR) GLR-1 at central synapses. We showed that GLR-1 levels are up regulated during activity blockade, a model for homeostatic plasticity, and that clathrin-mediated endocytosis is required for this compensation. We showed that following endocytosis, GLR-1 is sorted into either of two trafficking pathways (recycling versus degradation). We showed that ubiquitin, and two ubiquitin ligases, promote GLR-1 trafficking into the degradation pathway whereas RAB-2 promotes sorting into the recycling pathway. At cholinergic neuromuscular junctions (NMJs), we identified a novel retrograde signaling pathway. In this pathway, increased muscle activity induces the activity of a muscle transcription factor (MEF- 2), and MEF-2 in turn induces a retrograde signal that decreases presynaptic release of neurotransmitter. We propose three new Aims to characterize these two forms of homeostatic regulation. 1. Which Rab proteins regulate GLR-1 trafficking? Since Rab GTPases regulate specific steps in protein transport, defining phenotypes associated with inactivation of specific Rabs will allow us to experimentally define discrete steps in GLR-1 trafficking. We are particularly interested in endosomal Rabs, because changes in endosomal trafficking of GluRs has been implicated in several forms of activity dependent plasticity. There are 27 predicted Rab proteins in C. elegans, of which six are endosomal Rabs. We will determine which of these regulates GLR-1 trafficking (using either existing loss of function alleles or GTPase defective mutant transgenes), and will identify the membrane compartment where GLR-1 accumulates in each Rab mutant. We will also determine which Rabs are required for homeostatic up regulation of GLR-1 following activity blockade. 2. Regulation of the MEF-2 dependent retrograde signal by muscle activity. We will test whether changes in endogenous muscle activity alter MEF-2 transcriptional activity, and whether this is mediated by activity- dependent dephosphorylation of MEF-2 by calcineurin. We will determine if MEF-2 activity is specifically coupled to activation of nicotinic acetylcholine receptors. 3. Identifying downstream genes required for the MEF-2 dependent retrograde signal. First, we will do microarray hybridizations to profile gene expression changes associated with retrograde signaling. Second, we will conduct RNAi screens to identify additional downstream components. AEX-1, a C2 domain containing protein expressed in body muscles, was identified as a candidate downstream gene in preliminary studies. Third, we will characterize the role of AEX-1. Fourth, we will work upstream from RAB- 3, testing the role of known or predicted regulators of RAB-3 function in retrograde signaling. Together these four strategies should allow us to define the biochemical pathways coupling MEF-2 activity to changes in presynaptic release. In summary, our experiments will provide new insights into the specific post-synaptic mechanisms underlying two forms of homeostatic regulation. Moreover, by characterizing mutants in which homeostatic compensation is impaired, we will be able to critically evaluate the impact homeostatic regulation has for synaptic transmission, behavior, and development. Given the strong conservation of these pathways across phylogeny, it is likely that our experiments will provide new insights into the general mechanisms underlying these fundamental aspects of synaptic cell biology.